Thymic Transplantation in Complete DiGeorge Syndrome

DESCRIPTION (provided by applicant): This 5 year competing application describes an opportunity to explore the long term outcomes of thymus transplantation in detail, with particular focus on the role of thymic activity and T cell function. Over the last 15 years, our laboratory has established that thymus transplantation is a successful therapeutic strategy for infants born with complete DiGeorge anomaly (cDGA) who are athymic and thus have a fatal immunodeficiency. Thymus transplantation results in host T cell reconstitution and survival of approximately 73% of subjects. We now will address unanswered questions about the basic biology of thymus transplantation in our long term survivors. Questions include the following, 1) why do T cell numbers remain in the 10th percentile after cDGA subjects develop circulating T cells and T cell function? How long does the thymus function after transplantation? 2) Do the peripheral T cells undergo premature senescence and die at higher rates than normal from apoptosis? 3) How are host T cells restricted to host HLA after development in an unmatched donor thymus? What recipient cells are present in the donor thymus after transplantation that can effect positive selection? To address these questions, we will pursue three aims. The first specific aim will assess the etiology of low T cell numbers after transplantation. Numbers of recent thymic emigrants (RTE) will be quantified by flow cytometry. Thymic output of RTE will be quantified by in vivo deuterated water loading in cDGA subjects. The intrathymic proliferation of thymocytes will be quantified by determination of the signal joint to β T cell receptor rearrangement excision circle (TREC) ratios. These data will be evaluated to determine if thymic function decreases with time after transplantation. The RTE and TREC data from cDGA subjects will be compared to data from partial DGA and healthy children to assess relative thymic output in cDGA. The second specific aim will address the survival of peripheral T cells. Quantification of telomere length in naove CD4 cells will show if there is premature senescence of these cells. Studies of apoptosis will address whether peripheral apoptosis contributes to the low T cell numbers found in subjects with cDGA. The third specific aim will assess the binding of T cell receptors to HLA by tetramer experiments. The binding to class I and class II tetramers will be used to evaluate restriction to host and donor HLA. Affinity of binding to HLA Class I tetramers will be assessed for cDGA subjects with and without matching to the thymus donor and will be compared to the binding of subjects with partial DiGeorge anomaly. By comparing the outcomes of the experiments from cDGA subjects to those with partial DGA, who have lymphopenia, and to those of healthy age matched children, we can determine if thymus transplantation across an HLA barrier contributes to defects in T cell numbers after transplantation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Thymus transplantation is a promising therapy being developed for the fatal congenital anomaly, complete DiGeorge anomaly. Detailed evaluation of the research subjects will elucidate immune defects that remain in the subjects after transplantation which may allow improved medical management for these subjects and extension of this therapy to other patient groups. Project Narrative Thymus transplantation is a promising therapy being developed for the fatal congenital anomaly, complete DiGeorge anomaly. Detailed evaluation of the research subjects will elucidate immune defects that remain in the subjects after transplantation which may allow improved medical management for these subjects and extension of this therapy to other patient groups. __SpecificAimsTextDelimiter__ Specific Aims Transplantation of allogeneic postnatal thymus tissue into athymic infants with complete DiGeorge anomaly (cDGA) has resulted in a 73% survival rate (43 of 60). After thymus transplantation, the infants develop naïve T cells and antigen-specific T cell responses; the infants clear viral infections and do not require prophylactic antibiotics. Although thymus transplantation has been clinically efficacious, T cell numbers do not usually rise above the 10th percentile for age. Basic questions regarding the underlying biology of the immune reconstitution after thymus transplantation include the following: i) How long does the transplanted thymus function and why are T cell numbers low? We know the transplanted thymus is smaller than normal thymus, but are the low T cell numbers due to limited production from the small thymus (Aim 1) or are the T cells inherently different from those of normal children (Aim 2)? ii) How do host cells become restricted to host MHC in an unmatched thymus allograft (Aim 3)? We will address these questions, in the following 3 specific aims. Aim 1. Assess thymic function over time after thymus transplantation. We hypothesize that the transplanted thymuses have decreasing T cell production over the first 10 years after transplantation because of our finding that naïve CD4+ T cells decrease starting at 2 years after thymus transplantation. We will assess thymic function using three methods. First flow cytometry will be performed to measure the number CD4+ and CD8+ recent thymic emigrants (RTE, CD31+CD45RA+) in the blood. We expect cDGA subjects after transplantation to have lower numbers/mm3 of RTE compared to the numbers in healthy children. Lower RTE numbers/mm3 likely reflect fewer cells leaving the thymus, but may also reflect decreased lifespan of RTE. In the second assay of thymic output, we will quantitate the production of RTE in cells/μl/day by measuring the in vivo incorporation of deuterated water into CD4+ and CD8+ RTE over 9 weeks. These data, obtained in cDGA transplant recipients between 2 and 13 years of age will show if RTE output changes over time and will provide the RTE half life. Thirdly, we will quantify thymopoiesis using signal joint (sj)/β T cell receptor rearrangement excision circle (TREC) ratios. This ratio is not affected by a difference in size between the transplanted tissue and normal thymuses of healthy children. If the sj/β TREC ratio in the cDGA subjects is equivalent to that of healthy children, this indicates that thymopoiesis itself does not limit the number of RTEs, instead thymic size may be limiting. If the sj/β TREC ratio is lower in cDGA than in healthy children, then, for the amount of thymus allograft tissue in the cDGA subject, the thymocyte proliferation is lower than the proliferation in a similar amount of thymus tissue in a healthy child. Age matched, partial DGA subjects, who have not received a thymus transplant, but are reported to have small thymuses, and healthy children will be used as comparison groups for the sj/β TREC and flow cytometry data. The studies will be performed on subjects 2-3 years, 5±2 years, and 10±3 years of age, which will allow us to determine if RTE numbers/mm3, RTE production, and intrathymic proliferation decrease from approximately 1 to 13 years after transplantation. Aim 2. Assess mature T cell dynamics. We hypothesize that the low T cell numbers in the cDGA thymus transplant recipients are due, in part, to a limited lifespan of the T cells. We will quantify telomere lengths of T cells in cDGA subjects after transplantation to assess the capacity of those T cells to undergo further division. If we find short naïve CD4 telomere lengths (likely since partial DGA subjects have shortened telomeres), we will conclude that the subject's T cells have undergone premature senescence. To determine if increased apoptosis possibly contributes to low T cell numbers, we will quantify spontaneous apoptosis and activation induced cell death using flow cytometry based assays. The assays will be performed on cDGA subjects 5±2 and 10±3 years of age. Age matched partial DGA and healthy children will be controls for these assays. Aim 3. Assess MHC restriction of the subjects and restriction elements in donor thymus allograft biopsies after thymus transplantation. Our preliminary data from tetramer binding experiments indicate that peripheral T cells after thymus transplantation are restricted to host, not donor, MHC despite their education in an unmatched donor thymus. We will extend our preliminary data testing for MHC restriction at early time points after transplantation. In a new area of investigation, we predict that the affinity of T cell receptor binding to self MHC molecules will be higher if the thymus and recipient share MHC class I molecules and will test this hypothesis using novel HLA-A*0201 tetramers that have mutated CD8 binding sites. To explain host MHC restriction in an unmatched thymus, we hypothesize that MHC restriction occurs on host dendritic or epithelial cells within the unrelated donor thymus. To test this hypothesis, we will use immunofluorescent antibodies to MHC and dendritic cell markers to detect host dendritic cells in the allograft biopsies. We will also grow thymic epithelial monolayers from allograft biopsies and detect host epithelial cells by fluorescent in situ hybridization. The questions addressed above are pertinent to our small population of athymic children. The answers, however, will provide insight into mechanisms controlling thymus development and host MHC restriction.